Integrated Digital Health Intervention to Promote Engagement in and Adherence to Medication-Assisted Treatment

PROJECT SUMMARY/ABSTRACT
The prevalence of opioid use and related disorders has reached epidemic rates in United States.
Medication-assisted treatment (MAT), the use of pharmacotherapy in combination with behavioral therapies, is
associated with significant reductions in illicit opioid use. Buprenorphine, a partial opioid agonist, is one
pharmacological option for MAT that is growing in popularity because of its more flexible administration through
office-based programs. Despite its many advantages, nearly half of participants are unsuccessful in achieving
buprenorphine stabilization. Distress tolerance (DT), defined as the perceived or actual ability to handle
aversive physical or emotional states, is a transdiagnostic vulnerability factor implicated in the development
and maintenance of substance use. Targeting DT during substance use treatment may improve outcomes by
promoting the ability to persist in goal directed activity (e.g., abstinence) even when experiencing physical or
emotional distress. Personalized feedback interventions (PFI) represent a promising method to effectively
motivate engagement in and adherence to buprenorphine treatment, particularly among individuals
characterized by low DT. These interventions are generally brief, individually tailored, and have the potential to
be delivered via mobile platforms (e.g., computers, text message). Dr. Langdon's career goal is to conduct
patient-oriented research focused on the development and evaluation of novel digital health interventions to
enhance engagement in and adherence to MAT. The integrated training and research plans proposed in this
application will provide Dr. Langdon with advanced training in several critical areas needed to enhance her
program of research toward this career goal. In collaboration with her mentors, training will be targeted to the
following domains: 1) nature and treatment of opioid use disorders; 2) treatment development; 3) digital health
interventions; 4) clinical trial methodology; and 5) professional development. These training objectives will be
achieved through a combination of didactic and applied activities as well as the application of these skills in a
Stage 1 behavioral treatment development trial. Target areas for learning are directly linked to the specific aims
of this research study, which include (1) the development and refinement of an interactive computer- and text
message-delivered PFI, that incorporates DT skills training, for persons actively seeking outpatient MAT (PFI-
DT); (2) pilot testing the efficacy of PFI-DT for increasing motivation, abstinence, adherence, and retention to
treatment compared to a health education comparison condition; and, (3) examination of potential mechanisms
that may underlie the efficacy of the PFI-DT in improving outcomes, including distress tolerance, self-
regulation, and negative affect. This K23 Award would provide Dr. Langdon with a range of advanced skills
designed to complement her prior training so that she may successfully transition into an independent scientist
focused on addressing the public health burden of opioid use disorders through the development of effective,
easily-disseminated, technology-augmented interventions.

Public health relevance
PROJECT NARRATIVE Medication-assisted treatment, including buprenorphine, is a first-line treatment for opioid use disorders; however, despite its many advantages, nearly 50% of patients are unable to achieve stabilization and long-term recovery. The proposed study will test whether a computer- and text message-delivered intervention can promote engagement in and adherence to buprenorphine among persons actively seeking outpatient medication-assisted treatment. This digital health intervention has the potential to improve treatment outcomes and prevent future overdose in a high-risk segment of the population.